Nitric oxide inhibits Iron(II)2-Oxogluterate dependent demethylases to regulate DNA and mRNA methylation

ABSTRACT- Nitric oxide (NO) is an essential signaling molecule that mediates dichotomous effects along a
pathophysiological concentration gradient. Low levels maintain physiological homeostasis, while at high
concentrations NO contributes to disease pathogenesis. Although mechanisms of physiologic NO signaling are
relatively well established, these canonical pathways do not sufficiently explain how NO drives pathological
alterations in gene expression. Epigenetic mechanisms, such as methylation of DNA and RNA, are central
regulators of gene expression. Our recent publication and preliminary data demonstrate that NO inhibits DNA
and mRNA demethylases, which causes the enrichment of DNA and mRNA methyl-adducts on genes
transcriptionally regulated by NO. Specifically, our data demonstrate that a concentration gradient of NO
differentially inhibits the activities of both DNA demethylases (TET; ten-eleven translocation, ALKBH2) and
mRNA demethylases (FTO; fat mass and obesity associated protein, ALKBH5) by forming a dinitrosyl iron
complex (DNIC) at the catalytic mononuclear iron atom. We found that each of these Fe(II)/2-oxoglutarate (2-
OG)-dependent demethylases (2-ODD) had a different sensitivity to NO-dependent inhibition. In cells, this
inhibition resulted in gene-specific enrichment of 5mC on DNA and m6A on mRNA; both of which are critical
gene-regulatory methyl-modifications. However, it is unknow whether NO regulates methyl-adducts beyond m6A
and 5mC and whether changes in DNA and mRNA methylation mechanistically drive NO-mediated changes in
gene expression. Thus, we hypothesize that NO differentially inhibits DNA and RNA demethylases in a
concentration-dependent manner to modulate the distribution of methyl-adducts on DNA and RNA, which in turn
control the expression of specific NO-regulated genes. Aim 1 will use isolated 2-ODD enzymes to determine the
structure-function relationship of NO bound to each enzyme. Kinetic studies will delineate the differential
sensitivities of each enzyme to NO. These data will be applied to cellular models to define the effect of a
pathophysiological gradient of NO, through demethylase inhibition, induces differential profiles of multiple methyl-
adducts on DNA/mRNA. Aim 2 will use cell models to identify NO-regulated genes that are also enriched in DNA
and mRNA methyl adducts. With CRISPR techniques we will modify DNA and mRNA methyl-sites and measure
corresponding changes in gene expression to demonstrate a causal-link between NO-dependent DNA/mRNA
methylation and gene expression. These studies will elucidate a novel molecular mechanism of signaling
whereby NO regulates gene expression by inhibiting 2-ODD demethylases in a concentration-dependent manner
thus providing a foundational understanding of the role of NO dysregulation in pathogenic gene expression.

Public health relevance
Nitric oxide (NO) is a free radical signaling molecule that is necessary for normal physiology, but it is also associated with numerous pathologic conditions. Mechanisms to explain how NO regulates gene expression in various disease settings are not known. Studies in this proposal will investigate a novel molecular mechanism of how different concentrations of NO controls DNA and RNA methylation to regulate gene expression.